CANCER CENTER SUPPORT GRANT (COMPREHENSIVE)

The Fred Hutchinson Cancer Research Center is an independent, non-profit research center, incorporated in 1971 and established exclusively for cancer research. The Center is organized into five divisions: the three scientific Divisions of Basic Sciences, Clinical Research and Public Health Sciences, and the Administration and Development divisions. Scientific programs include: Basic Sciences - Biochemical Oncology, Cell Biology, Developmental Biologiy, Genetics, Molecular Biology and Immunology, Molecular Medicine (interdisciplinary), Tumor Biology and Viral Oncology. Clinical Research - Allogeneic Marrow Transplant for Malignant Disease, Autologous Marrow Transplantation, Biological Response Modifiers, Chemoimmunotherapy and Syngenic Marrow Transplantation, Experimental Pathology (interdisciplinary), Human Immunogenetics, Infectious Diseases, Pain & Toxicity Research, Pediatric Oncology, Clinical Pathology, Supportive Care and Transplantation Biology. Public Health Sciences - Biostatistics, Epidemiology and Cancer Prevention. Newly developing programs included in this proposal are Gastroenterology and Nutrition Research. This application requests renewal of the Center's existing Caner Center Support Grant (Comprehensive). Support requested will continue the development and maintenance of support for professional personnel (Senior Leadership, Major Program Heads, and Staff Investigators), division administration and planning, shared resources and development of the new programs mentioned above.